Targeting ASAP1-Controlled Signal Pathways to Inhibit Uveal Melanoma Metastasis

Project Summary: "Targeting ASAP1-Controlled Signal Pathways to Inhibit Uveal Melanoma
Metastasis"
Uveal melanoma (UM) accounts for about 5% of all melanomas and has an incidence of 4-11 per million
people per year in western countries. Although much has been learned about the signaling pathways that
control UM oncogenesis, far less is known about the pathways that control metastatic disease. Preventing or
effectively treating metastatic disease is critical because it occurs in about 50% of patients (most often in the
liver) and once present, the prognosis is dismal. Amplification of chromosome 8q is one of the strong
predictors of metastatic disease. ASAP1, which is located on chromosome 8q, has been shown to control
metastasis in breast cancer. ASAP1 is amplified in about 40% of UM patients, and increased ASAP1
expression levels are associated with increased metastasis and poor prognosis. Overexpression of ASAP1
in low-grade tumor cells increases cell migration in an in vitro wound-healing assay. Furthermore, ASAP1
has been implicated in the metastasis of several cancers and is thought to promote metastasis by directly
controlling the remodeling of the cytoskeletal architecture. We have recently begun to explore the molecular
pathways that control uveal melanoma metastasis and have preliminary data showing that ASAP1 controls
uveal melanoma cell invasion, proliferation, and metastasis in an orthotopic xenograft model of human uveal
melanoma. Furthermore, we have identified several tumor-associated transcription factors, including STAT4,
COUP-TF I, and COUP-TF II, that are activated by overexpression of ASAP1 in UM cells, suggesting a novel
mechanism by which ASAP1 may also control UM metastasis. Therefore, we hypothesize that ASAP1
promotes uveal melanoma metastasis by activating signaling pathways that induce tumor-associated
transcription factors and that inhibiting these pathways by pharmacologic inhibition will significantly reduce
metastatic disease. We will test this hypothesis by pursuing two aims. In Aim 1, we will identify ASAP1
domain(s) that promote UM cell invasion and proliferation. These studies will involve expressing full-length
ASAP1 and its serial deletion constructs following ASAP1 knockdown to determine the role of ASAP1
domains in UM cells. In Aim 2, we will assess the function of ASAP1-controlled transcription factor(s) in
uveal melanoma cell invasion, proliferation, and tumor metastasis. Cell culture experiments will involve either
knockdown of gene expression or pharmacological inhibition to determine the role of these transcription
factors in UM cells. In vivo experiments will determine whether pharmacologic inhibition of ASAP1- activated
transcription factors reduce tumor progression and metastasis in a xenograft model of human UM. For these
studies, we will use JAK inhibitors and CIA1, which inhibit STAT4 and COUP-TF II, respectively. This
research should provide us with new insights into the molecular mechanisms underlying metastatic spread of
UM and may lead to novel approaches to prevent or treat metastatic UM.